Molecular Genetics Resource Core

Molecular Genetics Resource Core – Summary
The Molecular Genetics Resource Core (MGRC) will provide a variety of services for the University of
Washington Center for Excellence in Opioid Research. We will provide state-of-the-art viral vectors for neural
circuit dissection, generate numerous viral-based CRISPR/Cas9 targeting vectors for in vivo molecular circuit
analysis, and provide access to platforms for the viral delivery of novel sensors and actuators developed by
UW addiction researchers. The UW MGRC will also generate novel mouse lines for UW addiction researchers
and provide access to existing mouse lines for researcher initiated investigations. A major provision of the UW
MGRC will be hands on training in molecular genetics techniques for graduate students, postdoctoral fellows,
and qualified undergraduates. We will also provide a Summer Workshop for the education and training of UW
addiction research trainees. Collectively the resources, education, and training provided by the UW MGRC will
facilitate the rapid dissemination of cutting-edge research on the molecular and genetic basis of opioid
addiction and prepare the next generation of scientists for careers in substance use disorder research.